Improving Accessibility of Vision Research and Therapy using an Open-Source, Extended-Reality Platform

Abstract
This project seeks to develop an open XR platform that can make accessible basic vision science assessments
and interventions to people living with visual impairment. In the US alone, over 6 million people live with low-
vision, which negatively impacts well-being, economic independence and societal participation. Despite
significant advances in healthcare, many researchers, clinicians and patients remain without ready access to the
specialized, lab-based instrumentation and software required for the accurate assessment and treatment of
vision loss. Our team seeks to leverage vision science insights, software development know-how, and extended-
reality (XR) headsets to develop a software/hardware platform that can render basic vision science assessments
and interventions widely accessible for all stakeholders. We take advantage of modern, commoditized, XR
systems to “bring the lab” to participants. Our proposal builds upon decades of research from the vision science
community, whose insights have long been used to benefit people with low vision. For example, automated gaze-
contingent procedures that measure basic perimetry, as well as contrast sensitivity, acuity and motion
discrimination in specific areas of the visual field have been transformative for understanding vision in those with
either peripheral or central visual field loss. Likewise, eye-tracking based interventions that target training to the
edges of functional visual fields in those with cortical vision loss, or to the preferred retinal loci of people with
macular degeneration have been transformative in helping patients regain visual function that is often not
accessible using other means. In this project, we will combine easy-to-use, high-resolution displays, with eye-
tracking and optional non-invasive electrical brain stimulation into a single device. This will revolutionize ability
to study low vision, and to deploy home-based but well-controlled visual “treatments”. In the R61, we will build
and test feasibility of research grade assessments and interventions addressing retinal blindness (macular
degeneration) and adult cortical blindness (stroke-induced). The R33 will support stage-1 feasibility trials
targeting these two low-vision populations as well as new projects to address pediatric cortical visual impairments
and amblyopia, and an open call for seed grants to support additional groups, extending the use cases of this
accessible XR platform. At all stages of design, development and implementation, teams of researchers,
clinicians, engineers and patients will work together to ensure that developed procedures address the needs and
goals of all stakeholders. This principled, trans-disciplinary, team-based approach is designed to maximize
access and thus, ultimately serve the lived realities of a great number of people with low-vision.

Public health relevance
Narrative The proposed research is relevant to public health as it seeks to make accessible basic vision science as- sessments and interventions to people living with visual impairment. This can give rise to greater understand- ing of mechanisms of vision loss, give rise new therapies for treating low vision, and to make these accessible to benefit millions of individuals suffering from low vision. The treatment of low vision is particularly relevant to mission of NEI to support research on visual disorders, mechanisms of visual function and preservation of sight.